Selective induction of alloantigen-specific humoral tolerance by MHC-Fc fusion proteins

PROJECT SUMMARY/ABSTRACT
Alloimmunization is the physiological response to allogeneic antigens encountered by the host during pregnancy,
blood transfusion, or transplantation. B cell-derived alloantibodies are generated in this response which do not
contribute to infection control but instead constitute a barrier to life-saving blood transfusion or transplantation.
The most prominent allogeneic humoral barriers are MHC class I human leukocyte antigens (HLA) due to their
strong immunogenicity and broad tissue expression. Donor-specific antibodies to these antigens are leading
causes of antibody-mediated graft rejection and ineffective platelet transfusion. To target HLA-specific antibody-
producing B cells, we have engineered MHC-Fc fusion proteins by linking an HLA class I antigen with the Fc
portion of an antibody molecule. Our preliminary data show that such HLA class I-Fc fusion proteins potently kill
B cell hybridomas with cognate specificities. This effect occurs in an antigen-specific and Fc-dependent manner
in vitro and in vivo. Here, we will extend our findings to examine these lead biologics in pre-clinical settings to
demonstrate their applicability. We hypothesize that MHC-Fc treatment can modify antibody-mediated disease
processes and attenuate alloimmunization to specific MHC class I antigens. We will test this central hypothesis
in three aims. In Aim 1, we will evaluate the efficacy and specificity of MHC-Fc treatment in a platelet
refractoriness model. In Aim 2, we will test the feasibility of desensitization by MHC-Fc treatment in a skin
transplant model. In Aim 3, we will test whether MHC-Fc treatment can induce antigen-specific humoral
suppression in a murine alloimmunization model involving bone fide polyclonal B cells producing anti-MHC class
I antibodies. Our proposed work allows critical evaluation of MHC-Fc prototypes in models that either mimic the
settings of their anticipated clinical applications (Aims 1 and 2) or offer a physiological source of B cells as the
therapeutic target (Aim 3). The results from these experiments will open a novel avenue of research in precision
medicine for the selective induction of antigen-specific humoral tolerance.

Public health relevance
PROJECT NARRATIVE Alloimmunization is the physiological response to foreign proteins encountered during pregnancy, blood transfusion, or transplantation. The resultant immune response to these foreign proteins constitutes a barrier to life-saving blood transfusion or transplantation. Here, we aim to develop a therapy to eliminate the B cell- derived portion of the alloimmunization to specific antigens as a means to eliminate this barrier.